Domain- and protein-selective BET mechanisms in cocaine-seeking behaviors

Project Summary
Epigenetic pharmacotherapy for substance use disorder (SUD) is a rapidly expanding area of research. With the
ability to bind to acetylated histones and regulate drug-induced transcriptional adaptations, members of the
bromodomain and extra-terminal domain (BET) family of proteins (BRD2, BRD3, BRD4 and BRDT) have
emerged as promising therapeutic targets. To date, however, only pan-BET bromodomain inhibitors, small
molecules that bind to both bromodomains (BD1 and BD2) within all BET proteins, have been tested in SUD-
related experiments. The use of these non-selective pharmacological inhibitors in SUD models limits our
mechanistic understanding of individual BET proteins, bromodomain-selective functions (BD1 vs. BD2), and non-
bromodomain BET interactions that regulate drug-induced neurobehavioral adaptations. New evidence from our
laboratory indicates that selectively targeting individual BET domains and proteins is a novel and effective
strategy to reduce cocaine-induced behavioral and transcriptional responses without causing sides effects
observed with pan-BET inhibitors. To build on these exciting data and to advance the field of epigenetic
pharmacotherapy for SUD, we propose to use highly selective, clinically relevant treatments, viral-mediated
approaches, and multiomic analysis to investigate domain- and protein-specific mechanisms of BET proteins
during cocaine-seeking behaviors. To achieve these goals, we will first investigate the behavioral and cell type-
specific transcriptomic responses of domain-selective BET inhibitors in cocaine economic demand and
reinstatement procedures. Next, using co-immunoprecipitation and mass-spectrometry, we will characterize
BRD4 interactome changes following short- and intermittent-access cocaine self-administration, and in functional
studies, we will use newly developed tools to identify a role for non-bromodomain mechanisms of BRD4 in
cocaine self-administration. Finally, we will interrogate novel transcriptional and behavioral roles for BRD2 in
cocaine-seeking behaviors. Together, these experiments will provide significant contributions to the field of
addiction epigenetics as well as novel therapeutic targets to reduce cocaine use and relapse.

Public health relevance
Project Narrative Although epigenetic therapeutics are promising treatment options for cocaine use disorder, many epigenetic inhibitors are non-selective and have adverse side effects, significant issues that restrict mechanistic insight and translational applications. The proposed studies will address these limitations by using novel highly selective, clinically relevant approaches to identify and characterize epigenetic-based treatments for cocaine use disorder.